Solute And Water Transport In Renal Epithelia

---- The Knepper Laboratory (ESBL) uses bioengineering and computational techniques, combined with quantitative mass spectrometry (MS) and next-generation DNA sequencing (NGS), to investigate the mechanisms of regulation of renal collecting duct function by vasopressin and other mediators. In the collecting duct epithelium, water transport is mediated by a vasopressin-regulated water channel protein, aquaporin-2 (AQP2). Studies have focused on cellular and molecular mechanisms of vasopressin action in collecting duct cells using systems biology approaches. In addition, substantial effort has been made to share computational tools and -omic datasets developed in ESBL with the research community (https://esbl.nhlbi.nih.gov/). ---- One experimental focus is on vasopressin signaling through the G-protein-coupled receptor, V2R. The experiments have used phosphoproteomics techniques to identify phosphoproteins perturbed in response to vasopressin V2 receptor occupation and to quantify specific sites of phosphorylation. These experiments demonstrated a highly selective phosphoproteomic response to vasopressin with quantifiable changes in only 2% of detectable phosphorylation sites. Most of the upregulated phosphorylation sites were in a sequence motif compatible with activation of protein kinase A (PKA) or other basophilic kinases. To test the roles of specific protein kinases in vasopressin signaling, the ESBL is using genome editing techniques (CRISPR-Cas9) to delete candidate kinases followed by phosphoproteomic profiling to identify targets of the deleted kinases. Deletion of both PKA catalytic subunits in collecting duct cells allowed identification of multiple novel PKA targets, including phosphoproteins whose molecular functions map to known functional effects of vasopressin. These ex-periments identified a number of additional protein kinases downstream from PKA that represent elements of a PKA-activated kinase cascade. PKA deletion resulted in loss of AQP2 mRNA and protein, which combined with ancillary data, showed that PKA is necessary for Aqp2 gene transcription. A new initiative in 2020-21 is based on the recognition that vasopressin signaling and elevations of collecting duct cyclic AMP levels drive cyst growth and presumably cystogenesis in collecting ducts in autosomal dominant polycystic kidney disease (ADPKD). We propose that we can leverage our work on vasopressin signaling in the collecting duct to a better understanding of ADPKD. ---- A second major focus is on how vasopressin regulates Aqp2 gene transcription. Studies employing various NGS techniques (RNA-Seq, ChIP-Seq, ATAC-Seq) have allowed comprehensive identification of vasopressin-regulated genes and genome-wide enhancer mapping. Identification of enhancers in the vicinity of the Aqp2 gene have provided a list of candidate transcription factors (TFs) for control of Aqp2 transcription. Among these was a so-called pioneer TF, C/EBP-beta, which was shown in ChIP-Seq experiments to bind to the predicted site in an Aqp2 -vicinal enhancer in a vasopressin-dependent manner. Nuclear proteomics demonstrated C/EBP-beta nuclear translocation in response to vasopressin. Additional candidate TFs are under investigation. ---- A long-term goal is to link the signaling studies described above to the studies of regulation of Aqp2 gene transcription described above in order to develop a comprehensive model that can explain how the kidney regulates water excretion and how this mechanism goes awry in water balance disorders. To directly identify pathomechanisms in water balance disorders, the Knepper Lab is using RNA-Seq in single microdissected renal tubules to identify signaling mechanisms responsible for transcriptional changes in animal models of water balance disorders such as the syndrome of inappropriate antidiuresis (SIADH), lithium-induced nephrogenic diabetes insipidus (NDI), and unilateral ureteral obstruction (UUO). ---- An additional focus is on data resources for sharing proteomic and transcriptomic data useful to the renal research community. While the data resources contain mainly data accrued in the conduct of studies of vasopressin action to regulate the aquaporin-2 water channel, the Knepper lab has recently moved resources into the use of NGS techniques and protein mass spectrometry for creation of atlas-type databases containing comprehensive transcriptomes and proteomes of each renal tubule epithelial cell type. Previously, we developed a strategy to combine fluorescence-activated cell sorting (FACS) with single-cell RNA-Seq (scRNA-Seq) to determine full transcriptomes for each of the cell types that make up the renal collecting duct epithelium. Current studies are using the same approach to map gene expression along the thick ascending limb (TAL) and distal convoluted tubule of the nephron. Among other observations is that there are two types of cortical TAL cells, characterized by expression of different Iroquois Homeobox TFs. Further studies will aim to identify physiological roles of both cell types in the regulation of water excretion and disorders thereof.